2', 3'DIDEOXYINOSINE FOR SYMPTOMATIC HIV POSITIVE CHILDREN

To evaluate and compare the long-term efficacy, safety and tolerance of two doses of ddI taken orally every 12 hours in children with symptomatic HIV infection who have one of the following: zidovudine intolerance,demonstrated disease progression after 6 months of ZVD or both drug intolerance and disease progression.